Sex Differences in Risk for Alcohol Use Disorder: Neural and Hormonal Influences

PROJECT SUMMARY/ABSTRACT
The sex gap in alcohol consumption is closing rapidly, due to alarming increases in alcohol consumption
among young women. As such, there is an urgent need to determine the factors underlying sex differences in
risk for AUD. Current addiction models propose three neurofunctional domains that drive problematic alcohol
use and therefore serve as candidate sex-specific risk factors: executive function, negative emotionality, and
incentive salience. Data from our lab and others suggest that poor inhibitory control, a key component of
executive function, is a stronger risk factor for women than for men. Moreover, we have preliminary evidence
that female drinkers show less engagement of neural circuitry underlying inhibitory control, and that this sex
difference is influenced by circulating levels of estradiol. However, the degree to which hormonally-moderated
sex differences in executive function extend to the negative emotionality and incentive salience domains, and
how these sex differences influence current and future drinking is unknown. Here we will determine: 1) the
neurobiological factors contributing to sex-specific risk for AUD in each of these three addiction domains and 2)
the degree to which sex differences in each domain influence current and prospective drinking. Female
drinkers will undergo fMRI to assess neural correlates of inhibitory control (i.e., executive function), negative
emotionality, and alcohol cue reactivity (i.e., incentive salience) at three phases of their menstrual cycle: early
follicular phase (low estradiol, low progesterone), late follicular phase (high estradiol, low progesterone), and
mid-luteal phase (moderate estradiol, high progesterone). Male drinkers will undergo three fMRI scans at
matched intervals. Immediately following each scan, participants will complete a session of free-access
intravenous alcohol self-administration. We will then follow participants for 18 months to longitudinally assess
changes in drinking patterns. We hypothesize that hormonally-moderated neural function underlying inhibitory
control and negative emotionality will be stronger predictors of current and future alcohol consumption in
women compared to men, whereas neural alcohol cue reactivity will be a stronger predictor for men. The
project capitalizes on the unique skill sets of the PI (an Early Career Investigator) and a strong, collaborative
investigative team. The innovative design will provide essential information regarding neural factors influencing
development and maintenance of AUD, and, critically, how this risk is influenced by sex and fluctuations in sex
hormones. Ultimately, this proposal is a crucial step in a line of research that will lead to the development of
sex-specific prevention and treatment efforts for AUD.

Public health relevance
PROJECT NARRATIVE The findings from this project will determine sex differences and the influence of sex hormones on neural function underlying risk for Alcohol Use Disorder (AUD), as well as how sex differences in neural function influence current and future alcohol consumption. The results will identify novel brain-based targets for sex- specific prevention and treatment efforts for AUD, and will provide information on the optimal timing of intervention for women, based on fluctuating sex hormones. As such, the project is a critical step towards the development of biologically-based, sex-specific interventions for AUD.